Gene Regulation and Memory in Bacterial Metabolism and Antibiotic Resistance

Project Summary:
Bacterial cells have a repertoire of responses that can be used to survive under different types of
environmental stress. Changes in carbon sources cause cells to turn on specific metabolic genes, which are
later repressed when those sources are depleted. Antibiotic exposure can trigger the expression of molecular
pumps that remove the antibiotic from the cell, or the production of enzymes that specifically inactivate or
degrade it. In a continually fluctuating environment, the process of turning genes on and off can be inefficient
and cause growth lags. Our work shows that bacteria combine their responses with phenotypic memory – the
passage of stable proteins from mother to daughter cells – which allows cells to avoid growth lags in fluctuating
environments.
Using a combination of quantitative microbiology, microfluidics, microscopy, sequencing, and modeling, we will
study the costs and benefits of gene regulation in fluctuating environments. We will measure and model the
fitness landscape of phenotypic memory using a library of strains with perturbed memory levels. Competition
experiments in fluctuating environments will be used to test biophysical and population dynamics models.
We present an innovative modular system that enables direct comparison of different gene regulatory
strategies – including responsive, bistable, and constitutive regulation – for any gene of interest. We apply the
system to study different classes of antibiotic resistance mechanisms. The proposed experiments make use of
a custom-built microfluidic ‘chemoflux’ system that we developed, in which bacterial populations grow in
monolayers, tracked at single cell resolution under the microscope, while the growth media can be arbitrarily
fluctuated in time. Using the chemoflux and our image analysis algorithms, we are able to simultaneously track
hundreds of independent bacterial populations, and thereby measure population dynamics in fluctuating
environments.
We combine experiments with biophysical modeling to gain insights into the costs and benefits of gene
regulation and memory. Models are parameterized using experimental data in a wide range of conditions, and
rigorously tested by their predictions on competition experiments in fluctuating environments. The range of
experiments and modeling employed address different aspects of gene regulation and memory, and allows us
to bridge from detailed laboratory measurements to the general biological principles that underlie bacterial
survival.

Public health relevance
Project Narrative: This project will determine how microorganisms use phenotypic memory mechanisms and gene regulation to survive under fluctuating stresses, including periods of nutrient starvation and exposure to antibiotics. By applying biophysical models, the project will enable precise predictions of bacterial growth and survival in complex environments. Our quantitative analysis of how bacteria use gene regulation and memory to survive will enable improvements in the clinical use of antimicrobials, in understanding treatment outcomes, and in controlling and perturbing host-associated microbial communities.